In-hospital use of Automated Insulin Delivery (AID): Current state and future potential

PROJECT SUMMARY/ABSTRACT
Dr. Michael Hughes, an instructor in Stanford University's Division of Endocrinology, Gerontology, and
Metabolism, is motivated by his personal experience living with type 1 diabetes to improve care and outcomes
for individuals with the condition. He has recognized the potential of automated insulin delivery (AID) systems
to enhance care for hospitalized patients with diabetes, based on both individual experience in caring for these
patients and the encouraging results from collaboration in a recent pilot study. This K23 grant will support Dr.
Hughes in developing expertise as an independent clinical researcher to use AID to improve patient care in the
hospital by providing a structured research program, targeted training, and personalized mentorship.
Hospitalized patients with diabetes are at higher risk of complications and death due to unstable blood
sugar levels. Traditional insulin therapy using multiple daily injections often fails to control blood sugar in the
hospital and results in high rates of both high blood sugar (hyperglycemia) and low blood sugar
(hypoglycemia). Despite 20 years of limited advancements in hospital diabetes care, advancements in
diabetes technology have been remarkably successful in outpatient settings. Recent trials testing the use of
continuous glucose monitors in the hospital have marginally reduced hypoglycemia without reducing
hyperglycemia. AID systems, however, offer a promising solution. They use real-time glucose data to adjust
insulin delivery up to 288 times a day, providing a level of control and adaptation not possible with traditional
insulin therapy methods. While some patients already use their personal AID systems in the hospital, there are
limited data from these experiences and no systematically established guidance to support this use.
The objective of the research in this proposal is to examine and optimize inpatient AID use. The research
aims to (1) evaluate the effectiveness of continuing home AID systems in the hospital among people with T1D,
(2) qualitatively identify and classify the barriers and facilitators associated with its use, and (3) develop
implementation strategies to advance and de-risk the use of AID systems in the hospital. This will provide
foundational data on the potential and limitations of current AID systems and advance their use in the hospital.
Dr. Hughes has assembled a highly qualified team of mentors and advisors who are experts in diabetes,
diabetes technology, inpatient diabetes management, qualitative and implementation science research, clinical
informatics, hospital technology integration, and hospital medicine. The strategic combination of coursework in
research methods and qualitative techniques, along with the Master of Science in Clinical Informatics
Management, will equip Dr. Hughes with the necessary skills to effectively integrate technology into the
hospital setting. Through the mentorship, training, and research proposed, Dr. Hughes will position himself as
a leading expert and use this opportunity to establish himself as an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Hospitalized patients with diabetes face increased risks of morbidity and mortality due to high and low glycemic excursions during acute illness. The current standard of administering multiple daily injection insulin therapy to manage diabetes in the hospital is often inadequate and results in unacceptably high rates of both hyperglycemia and iatrogenic hypoglycemia. This proposal aims to examine and optimize the use of automated insulin delivery systems in the hospital by evaluating their effectiveness, identifying barriers and facilitators to their use in the hospital, and developing implementation strategies to improve glycemic control for hospitalized patients with diabetes.